Mechanisms of bone fragility in Autosomal Dominant Osteopetrosis type II: from human to mouse and back

SUMMARY
Coupling, or communication between the bone-resorbing osteoclasts and bone-forming osteoblasts
during bone remodeling, is a key step in the bone remodeling cycle. While compelling evidence shows that bone
loss and fragility with age and osteoporosis result from corrupted coupling, the precise mechanism of osteoclast-
osteoblast communication remains unclear. Thus, although stimulating coupling is a theoretically attractive
therapeutic target, current treatments for osteoporosis, a common disorder affecting 54 million of the elderly in
the US alone, are limited to either inhibiting osteoclastic bone resorption or stimulating osteoblastic bone
formation. Our long-term goal is to determine the mechanism of osteoclast-osteoblast communication critical for
coupling of bone formation to resorption during physiological bone remodeling, using rare osteopetrotic diseases
as a tool. Rare bone diseases provide important insights into typical bone physiology and knowledge gained
from these diseases has already led to new therapies for osteoporosis.
In this proposal, we utilize samples from patients with autosomal dominant osteopetrosis type II (ADOII),
a rare inheritable osteopetrosis characterized by high bone mass and skeletal fragility and complement human
studies with mouse models. ADOII results from heterozygous mutations in the CLCN7 gene, which encodes the
ClC-7 Cl-/H+ exchanger essential for osteoclastic bone-resorption. While the lack of osteoclastic resorption
clearly contributes to bone phenotype, bone formation is also inappropriately high. In preliminary data
investigating the bone structural unit (BSU) composition of ADOII bones, we found bone formation is primarily
remodeling based, with excess bone formation called overflow remodeling. Osteoclasts are abundant and
scalloped cement lines suggest an intermittent pit-like resorption mode, which in combination with overflow
remodeling results in a characteristic puzzle-like bone structure. We hypothesize that the anabolically active but
poorly resorptive osteoclasts in ADOII overexpress anabolic coupling factors, inappropriately stimulating bone
formation to overfill the resorbed cavities and leading to disorganized puzzle-like bone and fragility.
We will test this hypothesis by combining in vivo and in vitro studies of ADOII patients and mouse models,
multimodal and multiscale imaging, biomechanics and spatial/single-nuclei transcriptomics. Specifically, we will:
1) test if the high bone mass and fragility in human and mouse ADOII is osteoclast-mediated; and 2)
investigate the mechanism of inappropriately high bone formation in ADOII by single nuclei
transcriptomic analysis of physically adjacent osteoclasts and osteoblasts.
The proposed studies take advantage of the unique resource of extant iliac crest bone biopsy specimens
from 15 ADOII patients from a Danish family carrying the CLCN7 (G215R) mutation and age and sex matched
controls, and two mouse models of ADOII, including the analogous Clcn7G213R/+ mutation. Through the lens of
ADOII, these studies will provide unique insights into osteoclast-osteoblast communication.

Public health relevance
NARRATIVE While compelling evidence shows that bone loss and fragility with age and osteoporosis result from corrupted coupling between osteoclastic bone resorption or osteoblastic bone formation, the precise mechanism of osteoclast-osteoblast communication remains unclear. Here we propose to determine the cell-type specific mechanism of coupling and identify molecular candidates expressed by these cell types using human and mouse models of autosomal dominant osteopetrosis type II (ADOII), a rare inheritable osteopetrosis characterized by high skeletal bone mass and also increased fragility, as our preliminary data suggest that this bone phenotype results from pathologic coupling. The results of these studies could be critical in the development of new treatments for osteoporosis, a common disorder affecting 54 million of the elderly in the US alone, as current treatments target either osteoclastic bone resorption or osteoblastic bone formation but none target the coupling process itself.